Sleep Impairment: A Mechanism Explaining Neuropsychiatric Symptoms in Alzheimer's

Project Summary/Abstract: Alzheimer’s disease (AD) and its related neuropathology are linked to a set of
neuropsychiatric symptoms (NPS) that come with marked clinical, personal and real-life burden. However,
the underlying neural mechanisms of NPS are poorly defined, hindering novel treatment approaches. Core
among these NPS are: 1) sleep disturbance, and 2) anxiety. Moreover, both sleep impairment and anxiety
are independently associated with a faster rate of longitudinal cognitive decline, reinforcing a particular
focus on their overlap. However, the possibility that AD pathology, impaired non-rapid eye movement
(NREM) sleep and the NPS feature of anxiety are actually inter-related, representing a novel brain
mechanism explaining why Aβ is associated with increased anxiety, has not been examined. Here, we seek
to test a core mechanistic hypothesis: The impact of Aβ burden on anxiety is orchestrated through beta-
amyloid (Aβ)-related impairment of NREM slow-wave sleep, which in turn, amplifies next-day anxiety
through impaired mPFC-amygdala emotional brain regulation. If supportive, these studies would (i)
advance our basic understanding of how AD-related pathology mechanistically impacts the NPS feature of
anxiety through impairment of NREM sleep, and (ii) establish sleep improvement as a novel modifiable
therapeutic intervention target that may de-escalate anxiety linked with the AD disease state, and potentially
the rate of longitudinal disease/cognitive decline.

Public health relevance
Project Narrative: Here, we seek to test a core mechanistic hypothesis: The impact of beta-amyloid (Aβ) burden on anxiety is orchestrated through Aβ-related impairment of NREM slow-wave sleep, which in turn, amplifies next-day anxiety through impaired mPFC-amygdala emotional brain regulation. If supportive, these studies would (i) advance our basic understanding of how Alzheimer’s disease-related pathology mechanistically impacts the core neuropsychiatric symptom of anxiety through impairment of NREM sleep, and (ii) establish sleep improvement as a novel modifiable therapeutic intervention target that may de- escalate anxiety linked with the Alzheimer’s disease state, and potentially the rate of longitudinal disease/cognitive decline.